Translational Genomics and Precision Medicine in Cancer Training Program

There is a critical need to train the next generation of translational cancer researchers in light of a new era of genomic medicine and big data. We must ensure that scientists are trained in the areas of highest need for translation of data and experiments into clinical practice. This application proposes renewal of the Translational Genomics and Precision Medicine Approaches in Cancer (TGP) training program developed at MD Anderson Cancer Center, where we have a single mission to eliminate cancer, in order to expand and enhance the training of outstanding predoctoral and postdoctoral fellows using an innovative curriculum and multidisciplinary approach centered on core competencies in state-of-the-art areas of translational research.
Objectives: 1) to provide a comprehensive program with both depth and breadth in areas important to the future of translational cancer research including translational genomics and precision medicine approaches, early detection and prognosis of cancer, as well as diagnostic applications; 2) to recruit top predoctoral and postdoctoral fellows interested in a career in translational cancer research in this area; 3) to provide fellows with an innovative environment, and with the infrastructure, faculty and administrative support to allow them to make significant contributions to the field and further the mission of the MD Anderson Cancer Center.
Rationale: TGP Training Program: The TGP program will provide the necessary education and training as well as infrastructure and oversight to develop innovative, big data genome scientists. A highly competitive selection process will identify outstanding candidates. Qualified candidates, in addition to a mentored research experience supervised by our outstanding training grant faculty, will gain individualized, interdisciplinary training in core competency areas critical to the future of translational science in a post-genome world.
Design of T32 Program: The T32 will offer 3 postdoctoral and 3 predoctoral fellowships designed around core competencies which include: 1) translational cancer research, to gain exposure to mechanistic studies in translational research and their importance to the human organism; 2) precision medicine to gain experience in state-of-the-art approaches to diagnose and treat cancer patients; 3) translational genetics and genomics to gain competency in understanding and implementation of cancer precision medicine; 4) bioinformatics, to learn how to read and interpret large datasets; and 5) exposure to clinical grand rounds, tumor boards, and industrial collaborations. Key activities include state-of-the-art curriculum, tumor boards, exposure to NCI clinical trials network and MD Anderson strategic alliances between academia and industry, and focused mentoring. All trainees will be required to have a strong interest in cancer research and for post doctorates, experience in cancer research. The training duration will be 2 years for postdoctoral and 3 years for predoctoral fellows with training faculty at UT MD Anderson Cancer Center and the UT Graduate School of Biomedical Sciences.

Public health relevance
The TGP training program will train the next generation of post-genome era cancer researchers, including multidisciplinary training in: 1) translational cancer research, to gain exposure to mechanistic studies in translational research and their importance to the human organism; 2) precision medicine to gain experience in state-of-the-art ways to diagnose and target treatment of cancer patients based on genomic profiles; 3) translational genetics and genomics, to gain competency in translational genomics needed for future understanding and implementation of cancer precision medicine; 4) bioinformatics, to learn how to read and interpret large genomics datasets; 5) exposure to relevant tumor boards and to industrial collaborations with academic faculty mentors on large scale genomic applications to cancer precision medicine. An outstanding training faculty has been assembled from the MD Anderson Cancer Center, the number one cancer center in the country, to educate and train predoctoral and postdoctoral fellows for advancing the mission of MD Anderson to provide state-of-the-art research-driven patient care.